Administrative and Professional Development Core

Summary
The Administrative and Professional Development Core of this COBRE is designed to achieve two
complementary goals: 1) to build a critical mass of researchers who leverage large biomedical data sets to
study and improve the health of women, and 2) to foster cross-disciplinary collaborations, which we expect will
lead to significantly increased NIH-funding on our campus. The strategy for achieving these complementary
goals includes a multi-pronged approach to recruit talented new faculty, to engage existing faculty who either
have backgrounds in data science or in women’s health research, to provide training and support for cross-
disciplinary research, and to develop a strong cadre of research project leaders, who will receive extensive
support for their goals of becoming independent, NIH-funded investigators. The APD Core will be led by the
Center Director, Heather Desaire, who brings two decades of NIH-funded research and grant management
experience. The aims of the core are: (1) Hire three new tenure-track faculty. (2) Develop the Research-
Engaged Faculty Fellows (Pilot Project) Program. (3) Support five Research Project Leaders each year. (4)
Center Coordination, Semi-Annual Review, Strategic Planning. The successful completion of these aims will
markedly increase the biomedical research capabilities on our campus, establishing at our institution a unique
center that leverages data science for women’s health research. Additionally, the cross-disciplinary
collaborations will stimulate innovation, a necessary component for addressing longstanding barriers in
biomedical science.